Mechanisms of Synergy between Oncolytic Herpes Simplex Virus and Trabectedin in Pediatric Bone Sarcomas

PROJECT SUMMARY/ABSTRACT
Osteosarcoma and Ewing sarcoma are the most common pediatric bone malignancies and efforts to treat
patients with advanced disease remain dismal, despite decades of research. To address this inadequacy, we
seek to leverage oncolytic virotherapy as a twofold attack against tumors: direct tumor cell lysis and antitumor
immune stimulation. However, previous trials of oncolytic herpes simplex virus (oHSV) in pediatric sarcomas
displayed limited responses, likely due to immunosuppressive monocytes and macrophages. To improve
efficacy, we combined oHSV with trabectedin, an FDA-approved DNA-binding agent known to mitigate
monocytes and macrophages. Strikingly, we found that the efficacy of this combination far surpassed our
expectations, inducing complete regressions and increased survival in multiple models of Ewing sarcoma and
osteosarcoma. The mechanism for this synergy remains unknown and understanding it is critical to optimize
approaches to therapy in human trials. In our preliminary single-cell RNA sequencing data investigating this
synergy, we observed far more viral transcripts in combination-treated tumors than in oHSV-treated tumors and
a decrease in the expression of genes associated with the intrinsic antiviral response, suggesting that trabectedin
selectively sensitizes tumor cells to infection. We also found that oHSV induced increased TRAILR2 death
receptor expression in tumor cells and increased TRAIL expression in NK cells, pointing to a second potential
mechanism for synergy through cytotoxic signaling. Based on these data, we hypothesize that trabectedin
augments oHSV efficacy through mechanisms that include transcriptional inhibition of tumor-intrinsic
antiviral responses and enhanced NK-mediated cytotoxicity via TRAIL-TRAILR2 signaling. Firstly, we will
investigate the decreased intrinsic antiviral response and the oHSV-induced tumor cell death pathways under
combination therapy via proteomic methods, including mass cytometry (CyTOF), western blot, and multi-color
immunofluorescence. To observe the related tumor cell sensitivity to oHSV, we will construct a luminescent
oHSV and monitor its spread in real-time. Secondly, we will analyze TRAIL, TRAILR2, TRAILR2 inhibitors, and
caspase-8 pathway expressions using CyTOF, western blot, ELISA, multi-color immunofluorescence, and qPCR,
in combination-treated tumors compared to oHSV-treated tumors. To determine whether TRAILR2 signaling is
necessary for combination efficacy, we will use CRISPR-Cas9 to knock out tumor cell TRAILR2 and compare
single and combination treatment efficacies in wild-type and knock-out models. Ultimately, we will illuminate
mechanisms of synergy through a two-pronged analysis, with the potential to reveal numerous generalizable
vulnerabilities in osteosarcoma and Ewing sarcoma for clinical application and the development of future
synergistic treatments against pediatric sarcomas.

Public health relevance
NARRATIVE The overarching aim of this study is to determine the mechanisms behind the highly successful treatment combination of trabectedin, an FDA-approved drug, and an antitumor virus against Ewing sarcoma and osteosarcoma tumors. This study will contribute critical insights into how tumor-specific viral infection and trabectedin work together advantageously to achieve tumor cell death. Discoveries from this study on how this treatment combination targets tumor vulnerabilities could prove generalizable to other cancers, rationalize clinical trials, and provide new therapeutic options for cancer.